The Role of dNp63 in Maladaptive Regeneration and Repair Following Severe Pulmonary Injury

Abstract
Unlike many mammalian vital organs, the lung exhibits a robust regenerative response to severe injuries such
as influenza infection, which primarily targets epithelial cells airways and alveoli. Quiescent lung-resident
epithelial progenitors enter the cell cycle, proliferate, and differentiate following lung injury, participating in two
distinct regenerative pathways: functionally beneficial regeneration and maladaptive tissue remodeling.
Intralobular airway-resident distal p63+ progenitors are one such progenitor cell type that migrates into the alveoli,
adheres to the denuded alveolar basement membrane, and rapidly proliferates to generate ectopic bronchiolar-
like tissue, forming honeycomb-like cysts that fail to resolve after injury and that do not participate in gas
exchange. Though ultimately a maladaptive injury response, this ectopic bronchiolization does appear to benefit
individuals with severe alveolar injuries by providing an “emergency” epithelial barrier. Distal p63+ progenitors
are the only cells in the distal lung that express the master epithelial regulator Trp63, specifically the ΔN isoform
(ΔNp63). ΔNp63 is highly active in the proliferative basal stem cells of other epithelial tissues such as the skin,
mammary, prostate, and trachea, in which it confers basal cells with their stem-like identity and transcriptionally
regulates the cellular processes of migration, adhesion, and proliferation. In my own preliminary data, I have
found that influenza-injured mice with broad ΔNp63 deletion in the airway epithelium display a completely
abrogated maladaptive alveolar remodeling response. Besides this data, there have been no studies directly
investigating the role of ΔNp63 in maladaptive remodeling and the mechanisms by which it promotes this
regenerative pathway. Aim 1 of this proposal will utilize conditional deletion of ΔNp63 in and lineage-tracing of
distal p63+ progenitors to investigate if loss of ΔNp63 causes a cell identity change in distal p63+ progenitors
following pulmonary injury. Intracellular flow cytometry, immunohistochemistry, and qPCR will be used to assess
the fate decisions of ΔNp63-/- distal p63+ progenitors upon deletion both prior to and following influenza injury;
pulmonary function tests will additionally be used to evaluate the physiological consequences of ΔNp63
knockout. Aim 2 will employ CRISPRa-mediated overexpression of p63 in tandem with in vitro and ex vivo
migration assays to determine if cell motility is affected by ΔNp63 overexpression in distal p63+ progenitors as it
is in other ΔNp63-expressing cell and tissue types. Finally, upon confirmation/identification of known and/or
previously unidentified ΔNp63 migration targets in distal p63+ progenitors, CRISPR-mediated knockout of these
targets followed by in vitro and ex vivo migration assays will be utilized to evaluate the importance of the ΔNp63-
driven migration program in injury-activated distal p63+ progenitor motility. These experiments will investigate
the role of ΔNp63 in distal p63+ progenitor fate choice and activation following injury, in turn yielding insight into
the mechanistic underpinnings of lung regeneration pathways following severe pulmonary injury.

Public health relevance
Project Narrative Respiratory infections and diseases are two of the top ten leading causes of death in the United States. This project seeks to uncover the drivers of maladaptive alveolar remodeling that occurs in individuals with severe pulmonary injuries such as viral pneumonia or interstitial lung disease, which can leave survivors with lastingly impaired pulmonary function that potentially contributes to mortality. Understanding the molecular mechanisms underlying the cell fate choice and migration - two crucial processes during maladaptive lung regeneration - of the maladaptive cell-of-origin will have major implications for the outcomes of cases of severe pulmonary injuries and will allow the field to begin investigating new ways to alleviate maladaptive alveolar regeneration and promote functionally beneficial lung regeneration in its stead.